NUTRITIONAL STATUS AND VLDL APO-B/TRIGLYCERIDE KINETICS

Examines the effect of nutritional status on rates of synthesis of very low density lipoprotein (VLDL) and the effects of these changes on plasma low density lipoprotein (LDL) concentration. Tests the hypothesis that rates of VLDL synthesis play an important role in determining plasma LDL concentrations. VLDL kinetics will be determined in normal volunteers during continuous feeding with a standard formula diet and after a 60h fast.